Mechanisms of Chromosomal Translocation

We have divided this project into two portions. 1) Genomic instability. Genomic instability is a hallmark of many malignancies. We studied mutation frequency in leukemic cell lines, using an assay for mutation of the X-linked hprt locus. We find that although some cell lines have dramatically increased mutation frequencies (100x that of normal peripheral blood T-lymphocytes), others have decreased mutation frequency with respect to T-lymphocytes. Through molecular analysis of the hprt mutants, we were able to determine that individual cell lines showed either gross chromosomal rearrangements (GCR) or point mutations, but not both, with rare exceptions. Of interest, two of three cell lines which display point mutations but not GCR are know to be mismatch repair deficient. We have begun to extend these findings by assaying the types (GCR or point mutations) of hprt mutations present in lymphoblastoid cells of patients with DNA repair/checkpoint lesions, such as Bloom's syndrome, ataxia-telangiectasia, and Fanconi's anemia.2) Recombinogenic genomic regions. An unsolved, fundamental question concerning chromosomal translocations can be phrased as follows: "Do recurrent, non-random translocations occur between "recombinogenic" regions of the genome that are extraordinarily susceptible to breakage/religation events, or are the regions involved not particularly recombinogenic, but simply regions that lead to the production of oncogenic fusion proteins which confer a growth advantage to the cell." To help address this question, we developed an in vitro system in which we can produce chromosomal aberrations, through the use of the Isce-I restriction endonuclease, that do not provide a growth advantage to the cell. Using this system, we have learned that gross chromosmal rearragnements are a rare result of improper DNA repair of a double strand break, with a frequency roughly 1% that of small interstitial deletions. We are using this system to determine if gross chromosomal rearrangements will be more common if additional breaks are introduced, via genotoxic chemotherapy such as etoposide or bleomycin and/or VDJ recombination. We are also using siRNA-mediated inhibition of non-homologous end joining (NHEJ) componenents to determine if cells with impaired NHEJ are more prone to gross chromosomal rearrangements. In addition, we have expanded our studies to assay tumors derived from epithelial cells in addition to tumors derived from hematopoietic cells.